Center for Population Health Research

Project Summary/Abstract
Montana is one of the most rural states in the country, and rural populations suffer disproportionately from
several adverse health outcomes. The Center for Population Health Research’s (CPHR) mission is to foster
investigator-initiated research aimed at improving population health in rural settings. Our Phase I Center of
Biomedical Research Excellence (COBRE) achieves this by supporting funded research projects and providing
investigators with funded project support, mentoring, and two research support cores. The CPHR Data and
Modeling (DM) Core provides researchers with statistical and environmental modeling expertise, support for
acquisition of secondary patient health and related data, and access to a high-performance computing
environment. The CPHR Intervention Support (IS) Core provides expertise and services for primary data
collection, including survey administration and qualitative method design, an opportunity that is now available
to researchers in this post-pandemic environment. Our core of early career investigators has recently identified
a need for support to enhance field-based primary data collection. CPHR investigators cover a variety of
clinical research topics, but one commonality across our center is understanding disease risk determinants in
order to inform, develop, and test interventions in rural communities. Thus, the CPHR early career
investigators that are engaging with rural patients and populations require the ability to mobilize recruitment,
data gathering, and community engagement in the field. Through this administrative supplement for equipment
purchases application (NOT-GM-24-021), we will be able to acquire and operationalize a mobile clinical
laboratory to support the identified needs of CPHR early career investigators and other CPHR-affiliated
researchers. The research capabilities supported by this mobile laboratory and related components will include
field-based community outreach, capture of clinical and environmental measures, patient/participant clinical
consultation, collection of biomonitoring data, secure and private administration of survey instruments, and
facilitation of qualitative data collection. By integrating this equipment and capability with our CPHR IS Core we
will be able to ensure sustainability for equipment operations through our established user charges structure.
The addition of these capabilities to our existing research mentorship and research support cores will serve as
a force multiplier for ensuring that our current and future investigators are able to develop and sustain impactful
independent research careers.

Public health relevance
Project Narrative The Center for Population Health Research (CPHR) is requesting NIGMS support for a mobile clinical laboratory. This equipment will support needs identified by early career CPHR investigators, including field- based community outreach, capture of clinical and environmental measures, patient/participant clinical consultations, collection of biomonitoring data, secure and private administration of survey instruments, and facilitation of qualitative data collection.